Integrative Predictors of Temporomandibular Degenerative Joint Disease

ABSTRACT
Temporomandibular Disorders (TMDs) represent a significant burden on musculoskeletal health, accounting for an
estimated $4 billion in healthcare costs annually. Pediatric Temporomandibular Degenerative Joint Disease (TM DJD) is
especially concerning, with risks including growth abnormalities, severe joint damage, and potential blindness. Addressing
the critical gaps in our understanding of pediatric TM DJD's progression, severity, and management is imperative. Our
research proposes innovative, evidence-based strategies to improve early diagnosis and personalized care, utilizing cutting-
edge multimodal imaging, artificial intelligence (AI), and machine learning.
Our strategy unfolds across two synergistic aims, each poised to significantly advance TMJ DJD diagnosis, prognosis,
and patient-specific treatment. Aim 1 employs advanced analytics, combining multimodal Cone-Beam CT (CBCT) and
Magnetic Resonance Imaging (MRI) registration, with articular disc quantitative markers. This aim introduces a novel
application of symptom phenotyping via mobile app tracking and biological marker assessments, integrating AI algorithms
to predict early disc and condylar changes in children—a critical step toward preemptive treatment strategies. Expanding
on Aim 1's foundation, Aim 2 leverages longitudinal datasets of pediatric and adult TM DJD patients to develop a
groundbreaking diagnostic and prognostic toolkit. This includes pioneering privileged information learning techniques to
merge advanced quantitative CBCT and MRI imaging features with clinical data, filling crucial gaps in real-world data
sources. A key innovation is the application of EMERSE, the Electronic Medical Record Search Engine, for comprehensive
clinical notes data abstraction, compared to large language models’ accuracy and reliability for information retrieval. Our
comprehensive approach evaluates the performance of feature selection, machine learning, and statistical models, refining
our preliminary Ensemble via Hierarchical Predictions through Nested model. We commit to rigorously testing our models'
usability, feasibility, and acceptability in clinical environments through a tri-phase assessment strategy, focusing on practical
implementation, expert clinician calibration, and integration into community dentistry for broader application. Aligned with
the NIH Heal Initiative, the NIDCR Temporomandibular Disorder Collaborative for IMproving PAtient-Centered
Translational Research, our proposed work also fulfills objectives within the NIH Strategic Plan for Data Science. Our
interdisciplinary team combines clinical experts at the University of Michigan and the University of the Pacific with the
computational expertise of partners in bioinformatics, natural language processing, statistical modeling, machine learning,
and software engineering from the Michigan Department of Learning Health Systems, the University of North Carolina,
and Isomics Inc. Leveraging a decade of collective experience and an established, robust infrastructure for quantifying
multimodal data, our research network is uniquely positioned to ensure the sustainability, accessibility, and utility of our
research outcomes for the TMD research and clinical communities. This collaboration is set to enhance clinical decision-
making and identify targeted treatment decisions for specific risk groups in pediatric TM DJD care.

Public health relevance
NARRATIVE Our initiative sets a new standard in the management of Temporomandibular Degenerative Joint Disease (TM DJD) across all ages, with a special emphasis on early diagnosis in children—a critical step for preventing long-term musculoskeletal complications. By integrating state-of-the-art multimodal imaging, precise artificial intelligence (AI), mobile app tracking, and real-world data, we aim to revolutionize clinical decision-making for both pediatric and adult patients. This comprehensive approach ensures the rigorous validation and widespread dissemination of our AI models, translating these technological advances into improved care tailored to the specific needs of every TM DJD patient, thereby enhancing outcomes across the entire spectrum of the disease.